Community Engagement Core

SUMMARY: Community Engagement Core
The Community Engagement Core (CEC) facilitates bidirectional interactions between community stakeholders
and the ISRP researchers who study polychlorinated biphenyls (PCBs), a class of Superfund chemicals. These
bidirectional interactions are critical to ISRP’s long-term goal of improving the health and well-being of
populations by preventing or limiting exposure to PCBs through scientifically-informed interventions. ISRP
studies demonstrate that inhalation of indoor air, especially in schools in the United States contaminated with
airborne PCBs, represents a significant and current public health concern for school-aged children. The CEC is an
important integrating core for the ISRP because it develops partnerships with communities impacted by PCBs,
serves as a source of information and educational resources for these communities, and acts as a liaison
between partner communities and researchers. The CEC is fully integrated with ISRP research projects and
other cores and has existing or developing relationships with the partner communities. Columbus Junction,
Iowa, and East Chicago, Ind., have been active participants in the ISRP AESOP (Project 3) prospective human
cohort study since 2006, during which time the CEC has facilitated a variety of school- and community-based
engagements. West Liberty, Iowa, is proposed as a new AESOP cohort community and will also be the
location of several proposed Project 4 activities focused on source characterization and remediation of
airborne PCBs in schools and homes (these activities are ongoing in Columbus Junction and East Chicago).
More than 100,000 people live within 5 km of the New Bedford Harbor Superfund site, where the current ISRP
Project 4 found large emissions of gas-phase PCBs. Building on this important discovery, Project 5 will
research how to reduce PCB emissions from New Bedford Harbor, and the CEC will facilitate bidirectional
interactions focused on “report-back” engagements designed to harvest community input and share relevant
ISRP research findings. Our community partners in Columbus Junction and West Liberty have already
brainstormed various health campaign designs and have agreed to assemble and maintain community
advisory boards to inform and oversee jointly-pursued activities.

Public health relevance
NARRATIVE: Community Engagement Core The ISRP Community Engagement Core will inform current and future interventions in school buildings that will decrease airborne PCB exposures for school-aged children and staff. This is a clear need as articulated by the East Chicago, IN, school district superintendent, a key project stakeholder. This project will also address the community-identified need to reduce obesity in school-aged children in Columbus Junction and West Liberty, IA.